Bromodomain-containing Protein 4 in Profibrotic Gene Expression and Lung Fibrosis

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is a fatal lung disorder of unknown etiology. IPF is
characterized by altered epigenetic state. Epigenetic alterations are potentially reversible, thus
are attractive therapeutic targets. Chromatin structural remodeling through histone post-
translational-modifications control transcriptional responses. Acetylated histone marks as well as
some transcriptional factors are recognized by bromodomains (readers). Bromodomain-
containing protein (Brd) 4 is a member of the bromodomain and extraterminal (BET) family, which
binds to cell type-specific enhancers and promoters. Brd4 has been reported to be essential for
enhancer-mediated pro-fibrotic genes expression in many organ fibrosis. However mechanisms
of how Brd4 regulates genome-wide pro-fibrotic responses and its interaction with other his
acetyltransferase, such as p300, is not clear. Fibrotic responses involve many cellular processes,
including epigenetic alterations. Our preliminary data show that by blocking Brd4, multiple
profibrotic genes can be downregulated; inhibition of Brd4 can disrupt the association of p300 and
H3K27ac with profibrotic genes promoter region. We hypothesis that Brd4 affects chromatin
accessibility, mediates the up-regulation of profibrotic genes through interaction with p300 by
acetylating active enhancer mark H3K27ac during lung injury and repair process. Our aims are:
1. Determine the effects of Brd4 inhibition on profibrotic responses in lung fibroblasts; 2.
Determine if Brd4 through p300 mediates histone acetylation to regulate profibrotic genes
expression, 3. Determine the in vivo targeting of Brd4 inhibition in pre-clinical models of lung
fibrosis. Results from this research will make a significant impact on our understanding of the role
of Brd4 in epigenetic regulation in the pathobiology of IPF.

Public health relevance
Project Narrative: Idiopathic Pulmonary Fibrosis (IPF) is a fatal disease with altered epigenomics and associated with high mortality. This proposal will explore if blocking Brd4, an epigenetic regulator, will block the upregulation of profibrotic genes thus alter the cell phenotype. This study will evaluate the efficacy of using Brd4 inhibitor as a therapeutic method to improve the resolution of persistent lung fibrosis; the completion of this study will further our understanding of this deadly disease and uncover novel therapeutic molecular targets.